The adaptor protein Crk in immune responses

Project Summary:
This proposal is a renewal application of a previous R01 (AI130197). During the last grant period, the PI has
published more than 30 peer-reviewed papers and applied for 10 patents. One of the most important
discoveries directly resulting from the last funding period is that the PI has identified three promising Crk
inhibitors and has filed a patent around these inhibitors (Patent #: 63/305,354). In the previous funding cycle,
the PI seeks to identify the mechanism(s) by which the small adaptor protein CT10 regulator of the kinase-like
(CrkL) and its phosphorylation (pCrkL) control NK cell activation and inhibition by using both human NK cells
and novel NK cell-specific conditional knockout mice. The long-term goal is to use this knowledge and the
novel imaging techniques to uncover the molecular basis of NK cell activation and inhibition and to develop
new treatments for human primary immunodeficiency diseases and chronic diseases such as cancer and viral
infection. After discovering the novel pCrkL inhibitors, we hypothesize that the newly discovered pCrkL
inhibitor determines Crk’s ability to interact with critical downstream signaling molecules and ultimately shapes
the actin cytoskeleton into a functional immunological synapse (IS), which can be potentially used to treat
infection and cancer. Guided by strong preliminary data, in this renewal application, we will test these
hypotheses via three Specific Aims: 1) Define the precise molecular mechanisms by how
phosphorylation of Crk-like (pCrkL) protein inhibitors affects NK cell functions. The proposed work will
bring cutting-edge imaging technology to the field of NK cell research. Experiments will determine where and
when Crk is phosphorylated at the IS, as well as how it interacts with key receptors, signaling molecules, and
the actin cytoskeleton with and without pCrkL inhibitors; 2) Determine the role of CrkL in T cells from
patients with partial DiGeorge syndrome (pDGS). By studying one of the most common (1 in 3,000 births)
immunodeficiency diseases, pDGS (mainly caused by CrkL haploinsufficiency), leveraging our previous
discoveries on pDGS that demonstrate defective integrin activation in NK cells in pDGS, we will determine how
the loss of CrkL affects CD8+ T cell integrin signaling and function in pDGS, which can generate novel
immunotherapy (e.g., modulating integrin signaling) to treat pDGS patients in the future; 3) Discover the role
of pCrkL inhibitors in cancer therapy. We identified several novel pCrkL inhibitors, which can interact with
and inhibit the pCrkL protein. It inhibits the proliferation of several solid tumor cell lines in vitro, and tumor cell
line-derived (CDX) xenograft and orthotopic patient-derived xenograft (PDX) mouse models; we will determine
this inhibitor and its analogs’ roles in immune cell (focusing on NK and T)-mediated immune responses against
solid cancers in vivo. The proposed work involves key signaling players and regulatory mechanisms and
generates a novel model system to determine the role of CrkL as a master regulatory molecule. It is broadly
relevant with direct clinical implications for treating primary immunodeficiency diseases and cancers.

Public health relevance
Project Narrative: Natural killer (NK) cells play a critical role in human host defense against viruses and cancer. Here, cutting-edge imaging techniques, a common human immunodeficiency (partial DiGeorge syndrome), NK cell-specific mouse “knockouts” will be used to define how Crk (an adaptor protein) and its phosphorylation act as a molecular switch to turn NK cell function on or off, as well as newly-discovered pCrkL inhibitors. These techniques and the knowledge they yield will use the specific phosphorylated CrkL (pCrkL) inhibitors that can harness the power of the immune system (including NK and T cells) to fight malignancies and viral infections. In this renewal application, we will investigate the molecular mechanisms of pCrk inhibitors in immune cell functions (Aim 1) and antitumor (Aim 2) and determine how the loss of CrkL affects CD8+ T cell integrin signaling and function in pDGS (Aim 3).